Recent Advances in HIV Research

PROJECT SUMMARY/ABSTRACT
Since 1998, the NIH-funded Centers for AIDS Research (CFAR) have hosted an annual one day National CFAR Scientific Symposium in conjunction with the annual CFAR Directors’/Administrators’ meeting. The purpose of the CFAR scientific symposium is to present, in a public forum, recent “cutting edge” advances in HIV research for an average attendance of approximately 250-300. Whenever possible, topics will reflect issues related to the OAR HIV/AIDS Priorities. The intimate size of the meeting promotes opportunities for interactions between junior and more senior investigators that would not be available at the larger annual scientific meetings related to HIV/AIDS. A key innovation in the last ten years is the addition of a peer mentoring workshop for attending early-stage investigators. The meeting location rotates so that it is hosted each year by a different CFAR site. This provides geographic variety for the venue and opportunities for a broader array of participants than for similar research symposia. As in the past, each hosting CFAR site has the flexibility to design the scientific agenda of the conference to meet the current interests and needs of the CFAR scientific community.

Speakers are selected from the various NIH-funded Centers for AIDS Research leadership, their scientific membership, and from nationally and internationally recognized research institutions. In addition to the participating CFAR Directors and invited leaders in the field, the remaining participants for the annual National CFAR Symposia are chosen based on specific criteria. First preference is given to junior investigators who have received developmental funds from an NIH-funded CFAR program; junior preference to young investigators with demonstrable potential in HIV/AIDS research; third preference is to other senior investigators engaged in HIV/AIDS research. Webcasts of the symposium are available for interested investigators who are not able to attend.

Public health relevance
NARRATIVE The purpose of the Centers for AIDS Research (CFAR) Symposium is to provide a venue to present and discuss recent advances in HIV research. This is a unique forum for presentations of the most “cutting edge” HIV research topics. The symposium provides an environment that fosters interactions between senior HIV investigators and early-stage investigators that will one day be leaders in the field.